Neuroskeletal crosstalk in load-induced bone formation

PROJECT SUMMARY/ABSTRACT
Peripheral nerve dysfunction is associated with skeletal fragility in humans and in preclinical models.
While proprioceptive deficits play a significant role in increased fracture risk, loss of local innervation may
deplete bone of neuronal factors critical for skeletal homeostasis. This presents new challenges for maintaining
bone health in patients with neuropathy and those undergoing nerve-modifying treatments. Specifically, it may
affect the therapeutic efficacy of weight-bearing exercise. Mechanically loading bone through exercise is a
well-established requirement for bone health. Compression of long bones results in skeletal remodeling to
increase strength. In addition, bone cells secrete neurotrophic cues after loading that may facilitate nerve
sprouting towards the skeleton, modifying endogenous skeletal innervation patterns. Considering this emerging
role of nerves in skeletal metabolism, local neuroskeletal signaling may be required to facilitate load-induced
bone formation. The central goal of this proposal is to investigate the plasticity and necessity of neuroskeletal
crosstalk in the anabolic response of bone to compressive loading. To accomplish this, the proposed research
is divided into two aims. In Aim 1, novel neuroskeletal niches involved in load-induced bone formation will be
defined. To investigate how native neuroskeletal niches are modified during skeletal adaptation, a 5-day
regimen of in vivo axial compression will be conducted on mice to induce lamellar bone formation, followed by
histology and imaging of the tibia. Nerves in bone will be mapped using a novel pan-neuronal Baf53b-Ai9
reporter mouse and immunostaining for nerve subtypes. In addition, local Ngf and Wnt1 gene expression will
be mapped in relation to defined neuroskeletal niches using in situ hybridization. To study the spatial
localization and relative quantities of axons, mineralizing surface, and gene expression, a novel image analysis
workflow (RadialQuant) will be used. In Aim 2, the necessity of these neuroskeletal niches for load-induced
bone formation will be evaluated. To test this, a model of tibial denervation will be developed by evaluating
neuronal loss after one-week of femoral and/or sciatic neurectomy using the imaging techniques employed in
Aim 1. To test the necessity of innervation in skeletal adaptation, the hindlimb will be denervated accordingly
prior to cyclic axial compression as in Aim 1. Techniques from Aim 1 will be used isolate the effect of loading
and denervation on axon density, mineral apposition, and gene expression. The long-term career goal of the
applicant is to run an independent research laboratory. In addition to the research plan, the training plan is
designed to achieve this goal through development of new technical skills, mentorship, and critical synthesis of
literature. The two-year fellowship will be conducted at the Washington University School of Medicine under
the mentorship of Dr. Erica Scheller and Dr. Matthew Silva, with expertise in neuroskeletal biology and bone
biomechanics, respectively.

Public health relevance
PROJECT NARRATIVE Peripheral nerve dysfunction is frequently associated with skeletal fragility and fracture risk, and a direct role of the nervous system has been implicated in skeletal homeostasis. Loss or modification of local neuroskeletal signaling in patients with neuropathy and those undergoing nerve-modifying treatments may diminish the therapeutic effect of loading and weight-bearing exercise on the skeleton. The goal of the research proposed in this fellowship application is to determine the plasticity and necessity of neuroskeletal niches in load-induced bone formation in order to improve skeletal health and treatment of skeletal disease.